5FU AND MITOMYCIN-C WITH RADIATION AND SURGERY FOR SQUAMOUS CELL CARCINOMA

To compare response rate and survival of previously untreated operable and inoperable patients with Stage III and IV squamous cell carcinoma of the head and neck treated with: a) radiation therapy followed by surgery alone as the control arm for the operable side. b) combination chemotherapy consisting of Mitomycin-C and 5FU concomitantly given with radiation therapy followed by surgical resection.